CORE--RESEARCH SERVICES

The specific aims of the Research Services Core are: 1. To provide support for computers, computer systems, and computer networks used by project investigators. 2. To provide analytical and statistical consultation to project investigators and associated fellows. 3. To furnish and maintain equipment and facilities for chronic animal monitoring. 4. To develop, and modify electronic and mechanic instrumentation in support of proposed research. 5. To provide service for computers, mechanical and electronic instrumentation.